The molecular mechanisms of progestin efficacy and resistance in EC-AEH

Abstract - Project 2: Establish the molecular signatures of progestin efficacy and
resistance in EC-AEH.
Progestins are synthetic steroids used to prevent the progression of atypical endometrial hyperplasia and early-
stage endometrial cancer (EC-AEH) in patients for whom fertility-sparing is desirable or when surgery is not an
option. Of the >20 progestins, only three are widely used to treat EC-AEH. Though initially effective, 25% of
patients do not respond, and 40% of patients relapse and develop resistance to progestin treatment, limiting
their widespread deployment and longer-term use. Improving progestin-based therapy is hampered by a lack of
mechanistic understanding of how they work and whether other progestins may be more effective than those
currently used. Canonically, progestins are thought to work cell-autonomously in tumor cells by binding the
progesterone receptor (PR), which regulates genes that cause tumor regression. However, many EC-AEH
tumors with low or absent PR still respond to progestins. Evidence is emerging that progestins also work cell-
autonomously through non-canonical pathways, such as activating other steroid hormone receptors. Further,
progestins also induce EC-AEH regression non-cell autonomously through PR in stromal and myometrial cells
and by modulating the immune response in the tumor microenvironment, though it is unclear how. To improve
hormone therapy, there is a critical need to decipher the mechanisms of how progestins drive tumor regression
cell-autonomously and through paracrine signaling in EC-AEH. To tackle this, we propose a functional genomic
approach using advanced CRISPR, mass spectrometry, and gene regulatory techniques using in vivo EC
models to systematically elucidate mechanisms of resistance and response for a panel of progestins in a uterine
environment. We have also developed a method to culture intact slices from EC-AEH tumors to compare the
effects of different progestins on the tumor directly and all cells within the tumor microenvironment using single-
cell RNA-seq. Using these methods, we will derive critical information about how different progestins work
through different mechanisms to induce tumor regression and identify sources of resistance and targets to
improve efficacy. The information gained from this Project is critical to the overall goals of the P01: identifying
the most promising progestins and the patients most likely to benefit from their use.

Public health relevance
Project Narrative Project 2: Establish the molecular signatures of progestin efficacy and resistance in EC-AEH. Despite advances in treating all other cancers, cases and deaths from endometrial cancer are rising in the United States. Progestins, synthetic versions of the hormone progesterone, are important but underutilized agents for preventing the progression of atypical endometrial hyperplasia and low-grade endometrial cancers into high-grade cancer but are ineffective in about a quarter of patients, and relapse rates are high. In keeping with the mission of the NIH, we propose to improve the health of women with endometrial cancer by using advanced molecular tools to understand the mechanism of how progestins work to develop more effective progestin-based therapies for the patients who will benefit from their use.